Michigan State University VDL VetLRN 2022

PROJECT SUMMARY/ABSTRACT
The overall objective of this proposal is to enhance the Michigan State University Veterinary Diagnostic
Laboratory (VDL)’s capability and capacity for surveillance, early detection and rapid response to animal food
or drug related illnesses or other large-scale animal food/feed emergency events requiring surge capacity
testing of implicated diagnostic or animal food/feed samples. The VDL is a full-service veterinary diagnostic
laboratory staffed and equipped to provide complete pathological, microbiological, and comprehensive
toxicological testing for FDA, CVM, and federal, state, or local agencies.
The VDL serves as the official veterinary diagnostic laboratory for the State of Michigan and is one of the
busiest in the U.S., conducting more than 1 million tests annually. The laboratory has an extensive client base,
with clients in all 50 states and Canada. Given this diverse client base, the VDL is uniquely positioned to
receive samples from across the US and Canada. The staff comprises 135 faculty and support staff with
expertise in bacteriology, virology, parasitology, anatomic pathology, clinical pathology, toxicology, nutrition,
immunodiagnostics and endocrinology.
The VDL houses wildlife biologists and diagnosticians from the Michigan Department of Natural Resources
(MDNR) and regulatory veterinarians from the Michigan Department of Agriculture and Rural Development
(MDARD). This unique arrangement facilitates efforts to address the important interface between domestic
animals and wildlife. The laboratory is fully accredited by the American Association of Veterinary Laboratory
Diagnosticians (AAVLD) to perform diagnostic testing on all animal species and is a Tier One laboratory in the
National Animal Health Laboratory Network (NAHLN) and a member of the Laboratory Response Network
(LRN), the Food Emergency Response Network (FERN), and the Veterinary Laboratory Investigation and
Response Network (Vet-LIRN).

Public health relevance
PROJECT NARRATIVE Microbial or chemical contamination of food or drugs poses a significant risk to both public and animal health and the laboratory testing supported by the Vet-LIRN program creates a mechanism for early detection of contaminated or adulterated animal feed or drugs. The network provides support for the required response capacity in the event of food- or drug- related animal injury or illness. Vet-LIRN directly supports national food safety and security through established protocols that coordinate efficient reporting to FDA and ensure a process to support rapid notification of appropriate public or animal health officials in a case of an emergency.